Molecular Biology Core

Description: The Molecular Biology Core provides service pertaining to cloning, sequencing and recombinant protein expression and characterization; measures fucosyl and sialyl histo-blood group antigens in samples to phenotype individuals in population and clinical human studies; conducts protein conjugation of synthetic oligosaccharide for preclinical studies; and performs and uses other diagnostic methods as appropriate. This core serves all projects.